ACE Network3 Supplement: Expanded ease-of-access data collection for underrepresented low-income African American populations at point-of-care

Abstract We request administrative supplemental funding to support the enrollment, inclusion, and molecular analyses of a total of 295 African-American families at two new point-of-care facilities affiliated with the Emory site of this network --the Marcus Autism Center Diagnostics Program (located in the same building as the Marcus Autism Center/Emory research program) and Hughes Spalding Children’s Hospital (located six miles away) -- over three years (Years 2-4) of our current UCLA-led ACE Network. We anticipate that this additional recruitment (an increase of 42% overall) will (a) increase power of hypothesis-testing in all Aims of the project, (b) increase socio- economic diversity and representability of the African-American population, particularly of its low-income subsections (a critical goal given hypotheses tested in Aim 2 and in light of recent health disparity findings), and (c) set the foundation for additional community engagement and subsequent minority African-American subject recruitment for this study and for other network studies in the future. !

Public health relevance
Project Narrative The current project (as funded for the next four years) provides for enrollment of 698 new African-American (AA) probands and their families across four recruitment sites. We are requesting supplemental funds to recruit and perform molecular analyses for an additional 295 families in the Atlanta, GA area, bringing the total number of families recruited to 993 (an increase of 42%) over three years. Recruitment will be performed in a manner that considerably broadens the socio-economic diversity of AA families enrolled to include families at point-of-care for clinical services affiliated with the Emory site, including, importantly, a community-based facility.